Glycopolymers as Cellular Glues

PROJECT SUMMARY/ABSTRACT
Antibiotics have improved our ability to treat infections, but antibiotic resistance is now an urgent public health
crisis, with global deaths from bacterial infections now exceeding 2 million annually. This rise in resistance
demands innovative strategies to combat pathogens effectively. As an alternative to pursuing small-molecule
antibiotics, I propose harnessing the body’s own immune mechanisms to combat pathogens effectively. I plan
to promote interactions between bacteria and human glycan-binding proteins on immune cells for new
antimicrobial therapies. This proposal aims to create “cellular glues” — molecules designed to enhance the
interactions between immune cells and pathogenic bacteria, ensuring the effective destruction of the
pathogens. I will develop glycopolymers that bind to glycan-binding proteins on the surface of the target
pathogen, Pseudomonas aeruginosa (PsA), and glycan-binding receptors on immune cells, specifically
antigen-presenting cells. I will assess the ability of glycopolymers to mediate 1) bacteria recognition,
activation, and signaling by dendritic cells, critical informers of T cell response and instructors of adaptive
immunity, 2) bacteria killing by macrophages, key phagocytic cells that also process and present antigens, and
3) improved innate and adaptive immune responses in vivo. I envision this approach will provide insight into
how glycan recognition by human lectins influences immune responses to pathogens. Moreover, this versatile
strategy could be expanded to tackle other multidrug-resistant bacteria like Enterococcus faecium and
Klebsiella pneumoniae, as these pathogens share carbohydrate-binding proteins that are targetable by this
design. A successful demonstration of the utility of this approach would lay the groundwork for directing
immune responses against growing threats like fungi or even tumor cells.

Public health relevance
PROJECT NARRATIVE The body’s natural defenses to prevent and clear infections rely in part on the ability of immune cells to recognize glycans on the surface of pathogens. This project aims to develop glycopolymer “cellular glues” that simultaneously bind to pathogens and immune cells. The formation of a complex between microbe, immune cell, and “glue” is anticipated to stimulate immune cells, specifically macrophages and dendritic cells, and improve various immune system functions, such as infection clearance and immune memory development.